BMT CTN Core - City of Hope National Medical Center

PROJECT SUMMARY
This grant application seeks to renew our status as a Core Clinical Center (CCC) and member of the Steering
Committee of the Blood and Marrow Transplant Clinical Trials Network (BMT CTN). The City of Hope (COH)
Hematopoietic Cell Transplantation (HCT) Program has focused its efforts over the last 50 years on the
development of Phase I, II and III clinical trials leading to improvements in HCT for the treatment of hematologic
malignancy and non-malignant disorders. In addition to developing laboratory-based translational research trials,
our program has conducted prospective clinical trials in areas such as reduction of relapse, graft-versus-host
disease (GVHD), and CMV infection. During our 20 years as a member of the BMT CTN, we have participated
in the development of clinical trials focused on important questions confronting HCT patients, several of which
were derived from early phase studies conducted in our program. This proposal summarizes COH CCC
capabilities for BMT CTN, our operational and scientific approaches, and our work in clinical trials both in our
own institution and in collaborations with the BMT CTN. As part of this application, we also propose a concept
for “a Phase 2, platform clinical trial of post-HCT maintenance therapeutics in patients undergoing allogeneic
HCT for treatment of TP53-mutated AML or MDS”. The outcomes of AML/MDS with TP53 mutation is dismal,
and development of effective therapeutic approach is a true unmet need. HCT is the only potentially curative
therapy for high-risk AML/MDS, including those with TP53-mutated diseases, but only a small fraction of patients
receives HCT, primarily due to advanced age, poor performance status, and uncontrolled disease. Even after
HCT, TP53-mutated MDS/AML are associated with low survival rates primarily due to a very high incidence of
relapse. The primary objective of our platform trial is to evaluate the efficacy of different maintenance therapies
for TP53-mutated AML/MDS as measured by 1-year progression-free survival (PFS). The first arm to be tested
will be magrolimab (MAGRO) and azacitidine (AZA). To further improve HCT outcomes in these high-risk
patients, we propose to capture a subset of patients before HCT and incorporate a multidisciplinary team
intervention aimed at detoxifying HCT by recording valid measures of functional recovery and creating a
paradigm for safer application of allogeneic HCT and proceeding to post-HCT maintenance. This trial is based
on the unmet need in the field as recognized at the BMT CTN SOSS 2021 and based on the experience and
expertise at COH investigating MAGRO/AZA as post-HCT maintenance therapy (NCT05823480, PI. Al Malki)
and assessment of frailty/resiliency in HCT candidates with a multidisciplinary approach to optimize care of these
patients at older age or inform clinical condition (NCT04914338, PI. Artz). Moreover, broad collaborations on
correlative science will significantly advance our understanding of this highly challenging disorder and interplay
between multiple immunologic factors involved with the HCT outcomes.

Public health relevance
PROJECT NARRATIVE City of Hope, as a Core Clinical Center of the Blood and Marrow Transplant Clinical Trials Network, proposes to continue leadership in the development and execution of prospective clinical trials addressing key issues in hematopoietic cell transplantation (HCT). We also propose a Phase 2, platform clinical trial of post-HCT maintenance therapeutics in patients undergoing allogeneic HCT for treatment of TP53-mutated AML or MDS, to be conducted by BMT CTN. This study addresses a true unmet need in this high-risk patient population, using novel approaches to improve HCT outcomes by post-HCT maintenance therapy and increase access to HCT and maintenance through a multidisciplinary team intervention in older or clinically infirm patients.